Longitudinal cohort study of SARS-CoV2 sero-conversion in a malaria-endemic community in Western Kenya

In many developing countries, the Covid-19 pandemic has had limited direct impact, including Kenya, which as
of 5 March 2021, has recorded only 107,329 cases and 1,870 deaths owing to Covid19. Although this limited
clinical impact is in part the result of strict travel and movement restrictions and under-reporting, these low
numbers contrast with seroprevalences of 4-8% in Kenyan blood donors, suggesting that a large number of
Covid19 cases in Kenya are subclinical. A further consideration in such settings is the potential for interactions
between SARS-CoV2 and endemic pathogens such as Plasmodium falciparum, which in Western Kenya is
transmitted perennially and intensely. These asymptomatic infections shape the risk of subsequent malaria and
have differential impact on hosts. In this sero-epidemiologic study, our specific objective is to investigate the
spread of SARS-CoV2 in a large, densely-sampled community cohort in rural Kenya. Our longitudinal cohort
consists of Kenyan household members of all ages enrolled since January 2020 in an observational study of
malaria transmission in the rural district of Webuye (parent study R01 AI146849, MPI: O’Meara/Taylor). From
550 people, we have collected blood from all participants during both i) monthly surveillance visits as well as ii)
at febrile sick visits, and collection will be ongoing through 2023. The SARS-CoV2 antibody Prevalence and
Acquisition in Rural Kenya (SPARK) study will be a sub-study of this parent cohort, in which we will test
monthly specimens collected prior to and during the Covid19 pandemic using an ELISA detecting neutralizing
antibodies to the SARS-CoV2 spike protein. Baseline sero-positivity will be measured in Jan 2020 specimens,
and sero-conversion as the appearance of neutralizing antibodies in a previously-negative person. Monthly
questionnaires will capture recent travel and illness not previously reported to the study team. We will then,
using P. falciparum detection and genotype data from the parent study, estimate the impact of P. falciparum
infection on the risk of SARS-CoV2 acquisition using longitudinal statistical modelling of the effect of
cumulative malaria infections and of specific parasite genotypes on the risk of sero-conversion and the risk of
acute illness during sero-conversion. Our multidisciplinary team will use samples and data from a large,
separately-funded, densely-sampled longitudinal community cohort to describe the community spread and
sero-epidemiology of SARS-CoV2 in a rural Kenyan setting and investigate its associated with P. falciparum
malaria.

Public health relevance
Project Narrative The Covid-19 pandemic has had limited impact in many austere settings that would appear very susceptible to severe effects, including where we work in Kenya, where the extent of subclinical infection and the potential interactions with malaria are poorly understood. In this sero-epidemiologic project, we will use samples collected through a longstanding, community-based longitudinal cohort with monthly sampling pre- and post- pandemic to understand the velocity of SARS-CoV2 acquisition in this rural, austere setting, and its interaction with Plasmodium falciparum malaria transmission, which is intense. The results will provide generalizable insights into the risk factors for sero-conversion to SARS-CoV2 and how this risk is modified by malaria.